Mechanistic studies of core Hippo pathway kinases-Equipment Supplement

PROJECT SUMMARY

The long-­term goal of our research is to understand the molecular mechanisms that control eukaryotic signaling
pathways. The objective of this application is to elucidate the principles that regulate the core kinases in the
Hippo pathway. The Hippo pathway controls organ size during development, tumorigenesis, and maintains the
stem-­cell niche through the coordinated activity of a kinase cassette that includes two kinases, Mst1/2 and
Lats1/2, and two accessory proteins, Mob1 and hSalvador. In Aim 1, we will establish a molecular basis for
understanding complex formation between SARAH domain proteins (hSalvador, Mst1/2, and RassF5) to inform
on how these proteins regulate pathway activity. In Aim 2, our investigations will further understanding of Mst1/2
activation and provide a mechanistic link between upstream pathway components and kinase activation. In Aim
3 we will elucidate the molecular mechanisms governing the activity of Lats1 and Mst2 activity. Outcomes from
the proposed work will fundamentally alter our picture of Hippo signaling in normal and disease states and
stimulate new directions of cellular and therapeutic investigation.

Public health relevance
PROJECT NARRATIVE The activity of the Hippo pathway regulates cell proliferation, stem cell maintenance, tumorigenesis. This work will determine the molecular mechanisms regulating kinase activity in the pathway. Insight gained from the proposed work will guide future efforts developing therapeutics that target the pathway with anti- cancer or tissue/organ repair and regeneration properties.